Harnessing epigenetic therapy for cutaneous squamous cell carcinoma by targeting histone H3K9 methylation

Keratinocyte carcinoma, including cutaneous squamous cell skin cancer (SCC), is the most common cancer in
the United States. SCC disproportionately afflicts military personnel and Veterans due to excessive ultraviolet
(UV) exposure during service. The VA Health Care System spends $137 million on KC treatment annually. In
addition to the high treatment costs, over 15,000 Americans die from cutaneous SCC each year. Currently, the
molecular drivers of SCC are incompletely characterized. Previous studies have primarily focused on the role
of UV mutagenesis in causing SCC. However, UV-induced driver mutations are often found in sun-exposed
non-malignant skin, suggesting that non-genetic mechanisms are also involved in UV-induced SCC
pathogenesis. UV might promote SCC development by causing epigenetic alterations, but these epigenetic
mechanisms and pathways are not clearly understood. In this application, we will investigate the role of the
hairless (HR) gene as an epigenetic regulator in SCC pathogenesis. HR encodes a histone H3K9
demethylase and regulates target gene expression epigenetically. HR-regulated genes are often involved
in cell proliferation, apoptosis, and cancer development. Mice with HR mutations exhibit a marked increase in
UV- and chemical carcinogen-induced skin tumors. Furthermore, HR is frequently deleted and inactivated in
human SCC tumors. The overall objective of this project is to investigate the mechanism of HR-regulated
histone methylation in SCC growth and progression in humans. The overarching hypothesis is that HR is a
novel tumor suppressor gene and that HR loss promotes SCC growth and progression through increased
H3K9 methylation. We will employ innovative research strategies using both preclinical models and
clinical specimens to rigorously test this project’s hypothesis in three Specific Aims. In Aim 1, we will
investigate the impact of HR deficiency in human SCC clinical specimens. In Aim 2, we will test the effects of
HR loss on cell proliferation, survival, and tumor growth in human keratinocytes and human SCC cells, as
well as identify and validate HR-regulated epigenetic changes and downstream pathways. In Aim 3, we will
investigate the role of histone H3K9 methylation in SCC pathogenesis and test if pharmacologic inhibition of
H3K9 methylation inhibits UV-induced and chemical-induced SCC development in HR-deficient mice.
Upon completing these studies, we expect to identify novel genetic and epigenetic determinants of SCC
pathogenesis. If successful, this project will facilitate future clinical trials validating the utility and efficacy
of histone methylation inhibitors in SCC prevention and treatment.

Public health relevance
Keratinocyte carcinoma (KC) is the most common cancer in the United States. KC disproportionately afflicts military personnel and Veterans due to excessive ultraviolet exposure during service. The VA Health Care System spends $137 million on KC treatment annually. Furthermore, over 15,000 Americans die from KC each year. The proposed research is relevant to the VA Health Care System because it focuses on generating new knowledge about the epigenetic basis of KC, which may result in novel prevention and treatment strategies. Such strategies could provide enormous benefit to millions of individuals diagnosed with KC annually in the United States. Thus, the proposed research has the potential to lead to significant advances in Veteran’s healthcare to reduce morbidity, mortality and cost.